Senescence tissue mapping and SASP Atlas for human somatic and reproductive tissues

ADMINISTRATIVE CORE - PROJECT SUMMARY
This Buck Institute Tissue Mapping Center (TMC) grant application proposes to map senescent cells in three
human somatic and reproductive tissues, i.e., ovaries, breast tissue, and skeletal muscle. It is crucial to provide
tissue maps of cellular senescence as well as a SASP Atlas of for these human tissues as (i) ovaries are one of
the first tissues to age, (ii) breast tissue has been shown to rapidly age and display high SASP gene expression
signatures in previous RNA Seq experiments, and (iii) muscle aging typically leads to impacted mobility or frailty.
The Admin core will oversee a leadership plan, a tissue-mapping coordination plan and a network coordination
plan to generate senescence tissue maps as part of the SenNet Consortium. The Admin Core will oversee that
data sharing pipelines within the TMC and with the SenNet network will be implemented and improved. The
collaboration between the Admin Core with the 3 other scientific Buck Institute TMC cores, the Biospecimen
Core, Biological Analysis Core and Data Analysis Core, will enable a streamlined tissue collection, data
acquisition and data analysis pipeline, in order to generate and prioritize senescence biomarkers expressed in
the somatic and reproductive tissues. Regular discussions and meetings between the Admin Core leaders and
leaders of the other scientific cores will allow efficient information exchange between all stakeholders. The
Admin Core in collaboration with the Data Analysis Core will develop and implement plans for submission of
data, protocols and resources to the SenNet Consortium and its data coordination center. The Admin Core will
ensure that any data submitted to the consortium complies with network-wide standard operating procedures
and SenNet policies. Collaborations with other TMC centers will enable comparisons of senescence markers
between tissues, and applying different technologies that are available at different TMC centers for tissue
mapping of multiple tissues, as the Admin Center will encourage all TMC centers to work together and to engage
in cross-training of technological skill-sets, use of novel instrumentations for scientists between centers, and
expanding intellectual knowledge about cellular senescence. Throughout the award period novel technological
advancements will be implemented more broadly into TMC workflows and tissue biological analysis pipelines as
they become available for network use. The Admin Core will coordinate such implementation in collaboration
with other Technology Development Centers and other TMC centers.
In summary, the Admin Core will coordinate all efforts of the TMC and build upon the existing strong scientific
expertise in cellular senescence research at the Buck Institute to establish a new Senescence Tissue Mapping
Atlas resource focusing on human ovaries, breast tissue, and skeletal muscle.